PATHOGENESIS AND NATURAL HISTORY OF GESTIONAL DIABETES MELLITUS

The project is a long-term study of the natural course of glucose tolerance in women who have had gestational diabetes mellitus (GDM). In addition to documenting the course of events, we are attempting to identify genetic and phenotypic characteristics at initial diagnosis of GDM that predicts the risk of diabetes mellitus outside of pregnancy.